Map the human airway basal cell niche and the role that FGFR2 plays within it

Project Summary/Abstract
Chronic obstructive pulmonary disease (COPD), asthma, primary ciliary dyskinesia (PCD) and cystic fibrosis
(CF), represent airway diseases caused by complex interplay of genetic and environmental factors. They are a
major cause of morbidity and mortality and effective therapies are variable. The heterogeneity of asthma and
COPD and the rarity of PCD and CF pose significant challenges to their study. Despite differences in their
pathogenesis these airway diseases have in common coordinated responses that involve crosstalk between
epithelial, mesenchymal, and immune cells that eventually leads to airway remodeling [2]. Fundamental to this
remodeling are basal cells (BCs), the major stem cell of the airway, and their niche [3]. Genetic mouse models
suggest that Fgf ligands secreted by adjacent mesenchyme bind to epithelial Fgfr2 receptors to maintain BCs
[4][5]. In response to injury, Fgf coordinates with Hippo and Wnt7b in an epithelial-mesenchymal signaling
network to achieve epithelial regeneration [6]–[8]. Is FGFR2 signaling important in human BCs? Surprisingly,
despite the importance of this question, little is known. We will test the following hypothesis: FGFR2 signaling
is essential in maintaining the self-renewal capability of the human adult airway basal cell. In aim 1, we will
define the basal cell niche in the human trachea and intercartilagenous airways using spatial transcriptomics,
ligand-receptor signaling analyses and in situ hybridization techniques. In aim 2, we will test that FGFR2
signaling is essential in maintaining human adult airway basal cells using human primary and induced
pluripotent stem cells derived BCs equipped with gene editing technology. At the conclusion of this aim we
have determined the importance of FGF in maintaining the BC program. Though this represents an ambitious
project in short timeframe, the tools, cells, protocols, tissue samples, and collaborators with appropriate
expertise, are all in place. The scope and goals of this project will expose me to a wide variety of techniques
suitable for an F32 candidate. Ultimately, this grant will generate exciting, novel data with which I can move
forward into the next stage of my career as a physician-scientist studying lung biology.

Public health relevance
Project Narrative: Diseases of the airways, such as chronic obstructive pulmonary disease (COPD), asthma, lung cancer, primary ciliary dyskinesia (PCD) and cystic fibrosis (CF) are a major cause of morbidity and mortality globally. Central to these ailments is pathologic airway remodeling driven by common coordinated responses involving crosstalk between epithelial, mesenchymal, and immune cells, ultimately leading to damaged and diseased conducting airways, yet very little is known about the cell type that is central to this remodeling: the human airway basal cell. The goal of this proposal is to define the basal cell signaling niche in human airways and interrogate key signaling pathways that are essential in maintaining the self-renewal capability of the basal cell, which has broad implications for our understanding of lung diseases.